"Examining Marketing and Parents’ Perceptions of Toddler Milk”

ABSTRACT
Toddler milk (i.e., an ultra-processed milk-based drink marketed to toddlers) is increasing in popularity in the US
and globally. However, toddler milk is not recommended by medical and pediatric associations, because it
usually contains added sugar, and early consumption of added sugar is associated with obesity and type 2
diabetes. Toddler milk packaging contains front-of-package (FOP) claims marketing the supposed “benefits” of
the product. Such marketing claims are not regulated by the Food and Drug Administration (FDA) and may
mislead parents about the healthfulness of toddler milk. There is a significant gap in understanding how
marketing elements on toddler milk packaging influence parents' perceptions of and beliefs about the product.
This gap represents a critical public health problem because understanding how marketing claims on toddler
milk packages affect parents is necessary to inform labeling policy and prevent parents from exposure to
information that is not supported by science. This project examines how toddler milk marketing influences
parental perceptions and beliefs via a systematic review, packaging content analysis, and focus groups with
parents. Using primary and secondary data, this study aims to: 1) Describe the determinants of toddler milk
purchasing and the influence of marketing on parents’ beliefs and behavior by conducting a systematic review.
Under this aim, the guidelines of the Preferred Reporting Items for Systematic Reviews and Meta-Analyses
(PRISMA) Statement will be used, and the existing literature around toddler milk labeling will be synthesized; 2)
Describe the nutritional qualities and FOP marketing claims of the top 5 toddler milk brands in the United States
and 22 Latin American countries by conducting a content analysis of toddler milk FOP labels. This aim will
elucidate and quantify food companies' labeling marketing practices around toddler milk; and 3) Explore how
marketing exposure, including reactions to FOP claims and warnings, influences parents' perceptions, beliefs,
and use of toddler milk. Focus groups with parents of toddlers will provide in-depth knowledge about how and
why the marketing practices identified in Aim 2 affect parents' perceptions and beliefs. The overall training
objectives are to develop a theoretical understanding of how marketing practices influence consumers'
perceptions and beliefs while developing skills to conduct systematic reviews, content analysis, and focus group
data analysis. The proposed research fits with NICHD's mission of “enhancing the lives of children,” and is timely
and significant because it will generate both an understanding of how food labeling influences parents and
evidence to support food labeling policy change. Ultimately, such knowledge has the potential to inform the FDA
so that it can regulate toddler milk packaging and protect parents from feeding their children an unhealthy product
during a crucial phase of development.

Public health relevance
PROJECT NARRATIVE Toddler milk, an ultra-processed milk-based drink recommended for children ages 9-36 months, often contains added sugar in its composition as well as scientifically unsupported marketing claims on the front-of-package (FOP) label. Research is urgently needed about parents’ understanding of toddler milk FOP claims, and this study will directly fill this gap by examining how toddler milk marketing influences parental perceptions and beliefs via a systematic review, packaging content analysis, and focus groups with parents. Contributing scientific evidence related to the food industry's marketing practices of toddler milk and how they affect parents' beliefs and perceptions of the product could inform the FDA and policymakers, informing future regulation of toddler milk packaging.